NMR Structure of the A-beta Peptide Inside Living Cells

? DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is characterized by the abundance of intraneuronal neurofibrillary tangles and the extracellular deposition of the Aβ peptide (hereafter referred to as Aβ) into amyloid. In AD brains, the Aβ undergoes a conversion (monomer → aggregate) and eventually precipitates as β-sheet like structures that have been linked to neuronal death. The chemical mechanisms associated with these conversions remains largely unknown. Due to its high propensity to aggregate, the Aβ is extremely difficult to handle in the laboratory. Despite these difficulties, our research group was one of the first to perform solution NMR studies of the Aβ, which along with subsequent work from other labs established that the Aβ adopts a predominantly random, unfolded structure in aqueous solution at neutral pH. A major advantage of the NMR approach is that it can provide atomic level aspects of the structures and dynamics in solution that are not available with other low-resolution techniques. In this application, we will take the next important and novel step, and will use NMR to study the structural ensembles of the Aβ peptide inside living eukaryotic cells. This work will establish whether or not the Aβ structures in vitro are the same as those in living cells in vivo. This is extremely important, in that the Aβ is an intrinsically disordered protein, which is a major clas of proteins that have a very flexible three- dimensional structure and are particularly sensitive t environmental perturbations, and that the complex, crowded environment of the cell could potentially alter the structure and function. We will perform two Specific Aims and attempt to determine the intracellular structure and dynamics in living cells using an array of NMR experiments. We will also explore the interactions between the Aβ and mitochondria. Furthermore, the classical view is that the Aβ is deposited extracellularly, although new data from transgenic mice and human patients demonstrates that the Aβ can likewise accumulate intraneuronally and contribute to AD progression, further emphasizing the importance of in-cell NMR studies.

Public health relevance
PUBLIC HEALTH RELEVANCE: The brains of patients with Alzheimer's disease are characterized by the abundance of intraneuronal neurofibrillary tangles and the extracellular deposition of the Aβ peptide into amyloid. Although much progress has been made toward elucidating the in vitro Aβ solution and amyloid fibril structures, it remains to be established i any of these structures correspond to the actual in vivo (native) structure. This is extremely important, as recent work showed that the in vitro, random unfolded structure of the protein α-synuclein does not correspond to the native in vivo tetrameric α-helical structure. The α-synuclein protein is the major protein component of Lewy Body deposits in Parkinson's disease. This research will determine the native structure of the Aβ peptide in human cells, which will assist in the design of drugs or biologics to prevent the formation of toxic oligomeric species.